Pathological Mechanisms of Immune-Mediated Cerebellar Ataxia with Associated Sez6L2 Autoantibodies

Project Summary/Abstract
Parent Grant Project: Sez6L2 autoantibodies have been reported in patients with subacute cerebellar
ataxia. Patients present with gait ataxia, slurred speech, and ocular motor symptoms. Some patients also
develop limb ataxia, cognitive deficits, bradykinesia, and/or Parkinsonism. These case studies have led to the
hypothesis that autoimmunity against Sez6L2 can directly cause cerebellar damage leading to ataxia. Sez6L2
is a transmembrane protein expressed by most neurons in the brain including Purkinje cells and granule cells of
the cerebellum. Currently, no animal studies have been performed to help understand if Sez6L2
autoantibodies are directly pathologic, whether they are a biomarker of cell-based autoimmunity to Sez6L2, or
whether are simply superfluous to the cerebellar pathology. We plan to test two mouse models of Sez6L2
autoimmunity in order to understand the mechanisms underlying cerebellar ataxia with associated Sez6L2
autoantibodies. Aim 1 of this project will determine whether mice immunized with Sez6L2 protein develop
cerebellar ataxia. We will also seek to understand the disease mechanisms using behavioral assessments,
immunohistochemistry, and flow cytometry analysis of infiltrating immune cell populations. Aim 2 will determine
whether Sez6L2 antibodies alone can cause cerebellar ataxia in mice, or block Sez6L2's complement inhibitory
functions in vitro. We anticipate that these studies will provide strong mechanistic evidence that the antibody
and/or full immune response to Sez6L2 is a pathological cause of ataxia and related symptoms. These studies,
coupled with the presently reported human case studies, should encourage prompt and routine screening for
Sez6L2 autoantibodies in suspected immune-mediated presentations of cerebellar ataxia. The results on disease
mechanisms could also help guide clinicians to the immunotherapies that may be most effective for patients
and help justify the risks of prolonged immunosuppression.
Administrative Supplement to Support Diversity in Health-Related Research Project: This
supplement will support the research and career development of an under-represented minority graduate
student. The candidate's research project will expand Aim 1 to test different mouse strains for autoimmune
susceptibility to Sez6L2 immunization and a new viral-vector based heterologous prime-boost immunization
strategy. It will also test whether the ataxia phenotype in Sez6L2 immunized mice requires functional cytotoxic
T cells or B cells. The mentored research and career development activities of this application will help
prepare the candidate for graduation and obtaining a competitive postdoctoral position for continued study in
the interdisciplinary field of neuroimmunology.

Public health relevance
Project Narrative When the immune system mistakenly attacks the cerebellum, the brain region responsible for coordinating movement, it can lead to symptoms of ataxia such as stumbling, falling, incoordination, and slurred speech. This project uses mouse models to understand how the immune system specifically damages the cerebellum when antibodies targeting a protein called Sez6L2 are present. We anticipate the results from these studies will guide physicians to currently available therapies or novel therapies that will best suppress the immune system to protect the cerebellum against autoimmune attacks linked to Sez6L2.